Interplay between mitophagy and substrate utilization in heart failure progression

PROJECT SUMMARY
Mitochondrial dysfunction and altered mitochondrial metabolism have been implicated in the development
of heart failure (HF). Mitophagy is a specialized autophagic pathway that mediates the lysosome-dependent
clearance of damaged mitochondria, and is essential for mitochondrial quality control. However, our current
knowledge regarding mitophagy in the heart and how it relates to myocardial metabolism is limited. Under normal
conditions, the heart relies predominantly on fatty acid β-oxidation (FAO) to fuel ATP production. In contrast, a
failing or hypertrophied heart usually shows impaired FAO and increased reliance on glucose utilization. Despite
significant advancements in understanding the regulatory programs that attenuate FAO, it is unclear how shifts
in myocardial substrate utilization contribute to the regulation of mitophagy. Therefore, this research proposal
focuses on the functional significance of cardiac mitophagy in response to altered myocardial substrate utilization
that occurs, for instance, in the setting of impaired FAO. The goal of this project is to delineate the novel
mechanistic link between mitophagy and myocardial substrate utilization in the heart, as well as to determine
whether mitophagy represents a novel mechanism and therapeutic target for the treatment of heart disease.
These studies will be facilitated by our recently described mt-Keima mouse model to monitor in vivo cardiac
mitophagy, as well as a set of innovative reagents to genetically and pharmacologically modulate mitophagic
flux. To directly assess the role of FAO in the heart, we have generated mice with cardiomyocyte-specific deletion
of CPT2 (CPT2-cKO), encoding a single gene required for FAO. We have demonstrated a decline in mitophagy
precedes the development of impaired cardiac function in FAO-deficient hearts. Our genetic analyses suggest
cardiac CPT2 deletion impairs the PTEN-induced putative kinase 1 (PINK1) signaling pathway, which positively
regulates mitophagy through mitochondrial ubiquitination. Augmentation of mitophagy by modulating USP30,
which mediates the reverse reaction, deubiquitination on mitochondria, mitigates the functional decline in FAO
deficient hearts. Therefore, in Aim 1 of the proposed studies, our goal is to define the magnitude and Kinetics of
cardiac mitophagy in response to impaired FAO, as well as to dissect the underlying molecular mechanisms
connecting mitophagy to myocardial substrate utilization. In Aim 2 of the proposed studies, we will genetically
and pharmacologically manipulate USP30 enzymatic function in the heart using mouse models that lack USP30
or are treated with a novel USP30 inhibitor. We will determine whether the detrimental cardiac phenotype,
induced by cardiac CPT2 deletion or pressure overload, could be reversed, at least partially, by restoring
mitophagy in cardiomyocytes via the inhibition of USP30. Completion of the proposed studies will produce critical
insights into the role of mitophagy in normal cardiovascular physiology and in pathological conditions, and will
fundamentally advance our understanding of the interaction between mitochondrial metabolism and
mitochondrial quality control in the heart.

Public health relevance
PROJECT NARRATIVE Mitophagy plays an essential role in preserving cardiovascular homeostasis by identifying and selectively eliminating dysfunctional mitochondria. This project aims to delineate novel molecular mechanisms connecting mitophagy to myocardial substrate utilization, and to assess the physiological implications when mitophagy is specifically altered. These studies will lead to a greater understanding of how myocardial energy metabolism is linked to mitochondrial quality control, and provide groundwork for the development of novel therapeutic approaches in the treatment of heart disease.